BLRD Research Career Scientist Award Application

Dr. Pran K. Datta is currently a Research Microbiologist at the Birmingham VA Medical Center
(BVAMC), AL, and a Professor at the VA-affiliated University of Alabama at Birmingham (UAB). He has a
long-standing track record in the mechanistic studies of colorectal (CRC) and lung cancer. Since 2010, he has
been contributing significantly to VA research and services through training, mentoring, and collaboration with
VA investigators. His established expertise in basic and translational cancer research has also attracted
investigators from diverse disciplines at the VA Medical Centers in the US, Vanderbilt University, and UAB,
which has led to collaborative grants and high-impact publications.
A seminal discovery from Dr. Datta's lab is the identification and cloning of a TGF-ß-receptor binding
protein STRAP (Serine Threonine Kinase Receptor Associated Protein) that inhibits TGF-ß signaling and
activates Wnt/ß-catenin and Notch signaling. The second seminal contribution of his study is to establish the
role of STRAP in activating the stemness of cancer stem-like cells. His third seminal contribution is to identify
a smoking-regulated miRNA signature that promotes NSCLC progression and chemoresistance. His high
impact research resulted in more than 70 papers and reviews in reputable top-tier scientific journals (some of
them with impact factor range 8.7-22.7). The fundamentals of the following projects are based on these high
impact and highly cited papers. Around 20 of his papers are cited more than 100 times each.
Project I: Translational research on colorectal cancer (CRC) pathogenesis and targeting by
nanotherapy. During the last 40 years, the proportion of CRC has increased by about 15% in the veteran
population and thus constitutes a significant risk for all veterans and their family members, including women,
especially over 50 years of age. Consistent with this, there were more than 52,000 new cases of colorectal
cancer cases in VA during the last 5 years. To combat this problem, the PI's lab will therapeutically target the
pro-oncogenic functions of STRAP by siRNA-based nanoformulation in potential treatment of CRC patients as
well as by sensitizing 5-FU and/or Oxaliplatin based chemotherapy.
Project II: Circulating microRNAs as predictive biomarkers for brain metastasis in non-small cell
lung cancer (NSCLC). Consistent with the fact that lung cancer remains the leading cause of cancer death in
the US veteran population, there were 41,780 new lung cancer cases and 19,543 lung cancer deaths among
the VA population during the last 5 years. The percentage of active-duty military personnel who smoked was
highest during the Vietnam and Korean Wars (75%). Similarly, 60% of Afghanistan and Iraq War veterans
used tobacco. The death records of 52,000 veterans of Vietnam War showed that these veterans died of lung
cancer at a 58% higher rate than veterans who did not serve there. To this end, Dr. Datta's lab is trying to
identify a miRNA signature in primary lung tumors that predicts NSCLC metastasis to the brain. Then this
miRNA signature will be validated using serum to stratify NSCLC patients at high risk for developing brain
metastasis and investigate their function in NSCLC progression and metastasis.
In addition to conducting these highly innovative and high impact research programs, Dr. Datta has
been recognized for his exceptional contributions to training, mentoring, and services at the local and national
VA. As the Director of Research in the Hematology and Oncology Division and of the T32 Training Grant, Dr.
Datta oversaw the research development and mentored junior faculty and clinical and postdoctoral fellows; a
number of those are in academia with high positions. Taken together, the RCS Award is expected to assist
him develop high-impact diagnostics and therapies for veterans and other Americans in need.

Public health relevance
Project Narrative Colorectal (CRC) and lung cancers remain the leading causes of cancer deaths in the US veteran population. During the last 40 years, the proportion of CRC has increased by about 15% in the veteran population and thus constitutes a significant health risk for all veterans and their family members. The aberrant regulation of tumor suppressor genes and oncogenes plays a pivotal role in the transformation of normal epithelium into primary and metastatic cancer. STRAP, a cellular protein, is upregulated in CRC, promotes tumorigenicity, metastasis, cancer stem-like cells, and drug resistance, thus contributing to worse survival of patients with chemotherapy. This study will discover novel and less toxic nanoparticles targeting STRAP in CRC, which will be used to codeliver 5-FU and Oxaliplatin. The second ongoing project deals with smoking-induced loss of antitumor functions of TGF-ß in lung cancer progression and metastasis. The proposed studies are very crucial for the development of successful therapeutic strategies for colorectal and lung cancers.